A recombinant elastin skin substitute for the treatment of burns

Project Summary
The goal of this project is to optimize and evaluate inSoma Bio’s proprietary recombinant elastin-based
biomaterial, Fractomer®, as an effective, low-cost skin grafting support matrix for the treatment of severe burn
wounds. Burns are most successfully treated by surgical excision followed by skin grafting; however many
patients with severe damage do not have sufficient healthy skin to support autograft procedures. To address this
need, biomaterial matrices, such as Integra Wound Matrix®, have been developed which reduce infection,
facilitate vascularization, and support regeneration of dermis tissue when applied to burn wounds. The current
market for dermal replacement, valued at over $7 billion, is dominated by animal-derived collagen due to well
established processes for isolating collagen from tissue and historical precedent for safety. However, due to the
cost of harvest from animals, they are notoriously expensive, with a single 40 cm2 sheet of Integra costing the
patient ~$10k. In addition, collagen cannot replicate the elasticity of natural skin, with elastin, not collagen,
providing skin with its resilient and pliable properties. As elastin production all but halts in adulthood, contraction
due to lack of elastin leads to scaring in newly developed skin. As a result, at least one third of burn treatments
using these materials require surgical revision. inSoma’s Fractomer® biomaterial is made from recombinant
elastin-mimetic proteins and represents an ideal substrate for the production of new skin grafting matrices which
better replicate the unique biomechanical properties of skin. The material has been shown to support in vivo
cellular infiltration, organized collagen deposition, vascularization, and biocompatibility during in vivo testing in
both murine and porcine models and, due to its temperature-sensitive phase transition properties, can be readily
molded into virtually any form including skin-like sheets. During the Phase I program proposed here, the company
will continue optimizing Fractomer sheet structure and formation methods to produce a material which supports
dermal regeneration through vascularization, cellular infiltration, and organized collagen deposition. A porcine
model of burn wounds will be used to compare Fractomer to Integra Wound Matrix®, the current gold standard
in skin grafting support matrices. The expected improvement in graft outcomes (e.g., fewer contractions and no
outright rejections) by employing the elastin-based Fractomer graft material represents a highly disruptive
product to the current dermal repair matrix market.

Public health relevance
Project Narrative Skin substitute biomaterials are largely based on animal-derived collagen, a protein that provides a porous matrix for cellular infiltration but is expensive and prone to contraction and scarring. inSoma Bio, Inc. is developing a recombinant elastin-based skin substitute which can provide the necessary resilience, elasticity, vascular support, and cellular ingrowth required for optimal skin regeneration. These properties, along with Fractomer’s cost-effective manufacturing process employing recombinant proteins, will support improved patient outcomes compared to prior-generation collagen matrices, and provide inSoma with a unique position in the multi-billion dollar dermal replacement market.